Population Structure and Clinical Impact of Multi-strain and Mixed-species Cryptococcal Infections

Abstract
Cryptococcal disease, caused by basidiomycete yeasts of the genus Cryptococcus, represents a sub-
stantial global health burden. Cryptococcus neoformans, the most common infectious agent, is ubiq-
uitous in the environment and it is likely that most people are exposed to multiple genetically
and phenotypically diverse Cryptococcus strains throughout their lifetimes. Despite this, human
cryptococcosis has historically been studied under the assumption that a majority of infections are
caused by single pathogenic strains. As a result, little is known about the incidence and prevalence
of multi-strain or mixed-species cryptococcal infections or their clinical impact.
In a preliminary study of patient samples from the Duke University Hospital System we de-
tected a surprisingly high number of mixed Cryptococcus infections. We now propose to charac-
terize the population genomic structure and epidemiological correlates of mixed Cryptococcus in-
fections, using a set of more than 500 patient samples from the southeastern US collected over the
last 30 years. We will analyze phenotypic and genomic heterogeneity within these patient samples
to identify mixed infections, and combine these data with with population genomic and phyloge-
netic analyses of environmental isolates from the same geographic region to understand the en-
vironmental origins of mixed infections. Information on the frequency and population structure
of mixed infections will be correlated with epidemiological analyses of patient demographics and
health outcomes to understand who is likely to get mixed Cryptococcus infections and what such
infections mean for health outcomes. We will also explore the impact of phenotypic heterogeneity,
a key characteristic of mixed infections, on sensitivity to antifungal drugs and interactions with
the host immune system.

Public health relevance
Project Narrative Cryptococcus neoformans is an opportunistic human fungal pathogen that is ubiquitous in the environment and is an important cause of disease for patients with HIV/AIDS, other autoimmune diseases, and solid organ transplants. The standard model for the study and treatment of cryptococcal disease assumes that infections are caused by a sin- gle strain or genotype but our preliminary studies demonstrate that mixed-strain Crypto- coccus infections are common among a patient population drawn from the southeastern United States. This research will advance public health by estimating the frequency and genetic structure of mixed Cryptococcus infections, identifying environmental lineages of Cryptococcus that contribute to mixed infections, and characterizing epidemiological correlates and health outcomes associated with mixed infections.